Contributions of astrocyte RelA signaling in aging-related neurodegenerative sequelae following TBI

ABSTRACT
Traumatic brain injury (TBI) is significantly correlated with increased risk for developing several
neurodegenerative disorders, including Alzheimer’s Disease (AD) and AD-related dementia (ADRD),
representing one of the most powerful environmental risk factors for AD/ADRD. Compounding these correlates
is that aging is a substantial factor in the incidence and vulnerability to TBI. Owing to the complexities surrounding
TBI as a progressive neurodegenerative disorder leading to AD/ADRD, the cellular mechanisms potentially
underlying the aging brain’s susceptibility to acquire degenerative responses remains elusive. To date, the bulk
of published findings related to TBI-related Alzheimer’s-like impairments have been examined using young adult
and predominantly male rodents, which does not accurately model the greatest at-risk population in humans.
However, our aging TBI model recapitulates several correlates of Alzheimer’s like impairments including chronic
memory impairment, exacerbated neuroinflammation, gliosis, phosphorylated tau, as well as microglial
phenotypes previously documented in both human’s and mouse models of Alzheimer’s disease. Guided by
preliminary findings, our overarching hypothesis is that in the aging brain following TBI, RelA drives exacerbated
astrocyte responses, underlying the aging brain’s susceptibility for persistent decremental outcomes related to
homeostatic astrocyte susceptibility, neuroinflammation, and neural network dysfunction. We believe these
altered responses, initiated by TBI in the aging brain ultimately manifest in correlates characteristic of progressive
neurodegeneration associated with AD/ADRD. We will pursue three aims to test this hypothesis using novel
genetic models for targeting astrocytes in young and aged mice to determine 1.) The susceptibility of aged
astrocytes to lose critical homeostatic features following TBI, 2.) The ability of astrocytes to regulate the
conversion of microglia towards decremental AD-associated inflammatory phenotypes following TBI, and 3.) The
role of astrocytes in the vulnerability of synaptic circuitry and impaired memory, a critical hallmark associated
with TBI/ADRD. Cumulatively, these studies will help to elucidate both the cellular and molecular substrates
through which the aging brain’s response to TBI facilitates progressive neurodegenerative sequelae that can
eventually lead to AD/ADRD. Our salient findings will ultimately determine the extent to which RelA is a critical
mediator in these AD-associated sequelae with the potential to elucidate new therapeutic targets toward their
prevention.

Public health relevance
Project Narrative Traumatic brain injury (TBI) is a complex and progressive neurodegenerative disorder affecting millions of people each year in the US, as well as being a known environmental risk factor for the development of Alzheimer’s disease-related dementia. However the mechanisms underlying the increased risk to develop Alzheimer’s disease-related dementia following TBI remain unclear. The salient findings from this project will significantly contribute to fundamental knowledge-base of the role of inflammatory response of astrocytes in the aging brain as determinants of outcome following TBI.